Mechanisms of natural killer cell resistance of treatment-persistent residual tumor cells in hematologic malignancies

PROJECT SUMMARY
Significance: Currently available pharmacological therapies for hematologic malignancies, including multiple
myeloma (MM) and myeloid leukemias often fail, despite ongoing treatment, to eradicate all malignant cells,
resulting in establishment of treatment-persistent residual disease TPRD (often referred to as “minimal” residual
disease, MRD), which serves as a reservoir for eventual patient relapses. Despite the critical role of TPRD/MRD
tumor cells as a barrier to cure, their biology and therapeutic vulnerabilities, including immune responsiveness,
has remained understudied. Preliminary data: Our recent studies and preliminary data indicate that treatment-
persistent cancer cells in acute myeloid leukemia (AML), MM, and solid tumors persist through cytotoxic drug
treatments via a non-genetic (and reversible upon drug withdrawal) low-Myc tumor cell state with transcriptional
changes resembling embryonic diapause, a stress-induced dormant stage of suspended development in many
species. In parallel to these studies, our collaborating labs characterized, through CRISPR and pooled pheno-
typic studies, the molecular determinants of response vs. resistance of treatment-naïve solid tumor or blood
cancer cells to natural killer (NK) cells; and how NK cell-induced adaptive transcriptional changes in tumor cells
may contribute to their persistence against NK cells. These studies identified several previously underappreci-
ated regulators of NK cell responses in chemo-naïve tumor cells; and observed that molecular signatures of
clinical resistance to immune checkpoint inhibitors overlap with signatures of NK cell response in treatment-
naïve tumor cells, suggesting orthogonal mechanisms regulating NK vs. cytotoxic T lymphocyte responses. No-
tably, TPRD/MRD tumor cells with embryonic diapause-like (EDL) chemopersistence exhibit complex and het-
erogeneous dysregulation of transcripts associated with NK cell resistance in treatment-naïve tumor cells. We
hypothesize that cytotoxic drug-persistent residual MM or leukemic cells may often exhibit, compared
to treatment-naïve cells, distinct patterns of responses to the cytotoxic activity of NK cells, as well as
both shared and distinct mechanisms regulating those responses. Approach: Building on our experience
with studies on NK cell resistance of treatment-naïve tumor cells and with experimental models of residual dis-
ease, we will (1) identify genomic factors that define responsiveness vs. resistance to NK cells using
myeloma and myeloid leukemia cells persistent to cytotoxic pharmacological therapies. We will also (2)
define adaptive molecular changes induced during TPRD tumor cell - NK cell interactions and charac-
terize their functional impact. Novelty-Impact: By focusing on the understudied biology of TPRD/MRD, this
project will provide new insights on how to develop individualized NK cell-based therapies for MM or AML with
persistence to cytotoxic drugs.

Public health relevance
PROJECT NARRATIVE Most deaths related to hematologic malignancies such as multiple myeloma (MM) or myeloid leukemias are caused by the inability of applied systemic treatments to eradicate all tumor cells and prevent formation of treatment-persistent residual tumor cell populations that will become the “seed” for eventual relapses and inability to achieve curative outcome. A better understanding of how this “minimal" residual disease (MRD) in MM or leukemia persists through pharmacological therapies is essential to develop new treatments that can decrease the burden of cancer-related deaths. This project seeks to study MM or leukemia cells which have developed persistence to chemotherapy or other drugs with cytotoxic activity against tumor cells and we will specifically characterize the mechanisms which regulate whether these MRD tumor cells will respond or not to natural killer (NK) cells, in order to better inform the development of future immunotherapies that can eradicate the residual malignant cells of MM or leukemias and bridge the gap towards curative outcomes for these diseases.